Cancer Prevention & Control: Multidisciplinary Training

DESCRIPTION (provided by applicant): More than 1.4 million new cancer cases are expected in 2009. Despite continuing improvements in treatment and prolonged survival, more than half a million Americans will die from cancer this year. Indeed, cancer accounts for one quarter of all deaths in the United States. Because lifestyle and environmental influences account for a substantial portion of the cancer burden, the importance of efforts in cancer prevention and control is increasingly recognized. In fact, the National Cancer Institute has noted the critical need to develop a cadre of highly trained research scientists with the necessary interdisciplinary skills to effectively and efficiently address behavioral factors in cancer prevention and control. The achievements of our graduates over the past decade reflect the success and the overall high quality of our training program in meeting NCI training goals. The successes of our past fellows include: 1) publishing at least two peer-reviewed research reports while in our program; 2) obtaining full-time cancer prevention and control research positions at academic institutions (67% had done so); 3) holding senior level academic positions with multiple R-01 grants (five graduates from the first funding cycle -now out of the program more than 5 years); 4) receiving NCI career awards (seven of our graduates); and 5) 100% of our minority graduates now hold faculty appointments at academic institutions where they are engaged in cancer prevention and control research. The goal of the proposed training program is to foster the development of cancer prevention and control researchers through an intensive postdoctoral training program. The Specific Aims are: 1) To provide postdoctoral fellows a specialized curriculum for education in cancer prevention and control, integrating behavioral, medical, biological, epidemiological, and community perspectives. 2) To teach postdoctoral fellows interdisciplinary research approaches in cancer prevention and control through hands-on participation in ongoing extramurally-funded research programs. 3) To foster the development of independent research careers in cancer prevention and control among postdoctoral fellows through both formal instruction and direct experience with writing research papers and grant applications with the guidance of their research mentoring team.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cancer is, and will continue to be, one of our greatest national health issues. Researchers trained in cancer prevention and control are a key element in combating both the incidence of and suffering associated with cancer. To that end, we propose to continue our successful postdoctoral training program to produce the next generation of independent cancer prevention and control researchers. Project Narrative Cancer is, and will continue to be, one of our greatest national health issues. Researchers trained in cancer prevention and control are a key element in combating both the incidence of and suffering associated with cancer. To that end, we propose to continue our successful postdoctoral training program to produce the next generation of independent cancer prevention and control researchers. __SpecificAimsTextDelimiter__ 1. Statement of Applicability This renewal application for the R25T grant to support postdoctoral training in cancer prevention and control was submitted in response to Program Announcement PAR-06-511, which identified the need for multi- disciplinary training for new investigators in cancer prevention and control. After reviewing the guidelines for the R25T and T32 funding mechanism, we concluded that the R25T was the appropriate source of funding for our postdoctoral training program, "Cancer Prevention and Control: Multidisciplinary Training." Our decision was based on three factors. First, the R25T Cancer Education and Career Development Program is to support the development and implementation of curriculum-dependent, team-oriented programs to train postdoctoral candidates in cancer research team settings that are highly interdisciplinary and collaborative, whereas the T32 focuses on specialized or sub-specialized training. Interdisciplinary and collaborative research is central to our program. For each of our fellows, a multidisciplinary mentoring team is established, consisting of at least two members of the mentoring faculty from different disciplines. [These disciplines include epidemiology, cancer genetics, oncology, psychology, public health, biology and medicine.] In addition to the multidisciplinary composition of mentoring teams, the R25T program calls for the development of an innovative Specific Curriculum, whereas the T-32 does not. Our program has a formal sequence of courses addressing critical areas in cancer prevention and control research. Thirdly, the R25T program requires thorough evaluation of the effectiveness of the program and the T-32 does not. Our program includes specific procedures for program, mentor and fellow evaluation throughout the course of the program. We also track fellows after they complete our program to help evaluate the long-term impact of our program. The proposed program outlines a comprehensive plan for multidisciplinary post-doctoral training in cancer prevention and control, and meets all the requirements of the R25T mechanism. 2. Specific Aims More than 1.4 million new cancer cases are expected in 2009 (American Cancer Society: Cancer Facts and Figures: 2009). Despite continuing improvements in treatment and prolonged survival, more than half a million Americans will die from cancer this year. Indeed, cancer accounts for one quarter of all deaths in the United States. As the baby boomer generation reaches old age in the next few decades, cancer is likely to become the leading cause of death in the United States. Because lifestyle and environmental influences account for a substantial portion of the cancer burden, the importance of efforts in cancer prevention and control is increasingly well recognized. Changes in behavior (e.g., reduced smoking, increased participation in screening) are important contributors to recent declines in cancer rates. Clearly increased efforts to address behavioral factors in cancer prevention and control are warranted. The importance of behavioral factors in cancer prevention and control has been highlighted by the National Cancer Institute, as well as the Institute of Medicine. Blue ribbon reports have emphasized the need for new efforts in research (i.e., the interactions among psychological, social and biological processes in cancer), as well as research initiatives in basic behavioral and social research aimed at increasing our understanding of the mechanisms of behavioral change (e.g., smoking) from the individual level (e.g., risk perception) to the group (e.g., family influences) and society (e.g., social class) levels, with the goals of preventing cancer and improving quality of life among cancer patients. These reports also note the critical need to develop a cadre of highly trained research scientists with the necessary multidisciplinary skills to effectively and efficiently address these complex issues. The goal of the proposed training program is to foster the development of such researchers through a broadly based postdoctoral training program emphasizing behavioral issues in cancer prevention and control. Fellows entering the program will have: advanced degrees in either Psychology, Public Health, Medicine, or a related discipline; have demonstrated research abilities, and show a strong commitment to a career in cancer prevention and control research. Specific Aim 1: To provide postdoctoral fellows a specialized curriculum for education in cancer prevention and control, integrating behavioral, medical, biological, epidemiological, and community perspectives. Specific Aim 2: To teach postdoctoral fellows interdisciplinary research approaches in cancer prevention and control through hands-on participation in ongoing extramurally-funded research programs. Specific Aim 3: To foster the development of independent research careers in cancer prevention and control among post doctoral fellows through both formal instruction and direct experience with writing research papers and grant applications with the guidance of their research mentoring team.